Biennial Meeting 2018

Conference for Food Protection Project Summary The Conference for Food Protection is a nonprofit organization established in 1971. The structure of the Conference provides a representative and equitable partnership of regulatory, industry, academia and consumer professionals. The goal of the Conference is to identify problems, formulate recommendations and develop practices that promote food safety and consumer protection. The Conference convenes a meeting every two years with work being carried on by committees and the Executive Board between these biennial meetings. Food security concerns, the ever-changing world of foodborne illness, rapidly developing food technologies and marketing innovations challenge all groups to work together. The success of the Conference is a function of its structure, its process and the expertise and collaborative spirit of its members. A major focus of the Conference for Food Protection is collaborating with the USDA and FDA to disseminate information regarding food safety matters that fall under their jurisdiction. The Biennial Conference produces recommendations from three councils, with regard to the FDA Model Food Code, which the Conference for Food Protection’s Executive Director communicates through a letter of recommendations to the Food and Drug Administration.

Public health relevance
Conference for Food Protection GOALS The Conference for Food Protection is a nonprofit organization established in 1971. The structure of the Conference provides a representative and equitable partnership of regulatory, industry, academia and consumer professionals. The goal of the Conference is to identify problems, formulate recommendations and develop practices that promote food safety and consumer protection. The Conference convenes a meeting every two years with work being carried on by committees and the Executive Board between these biennial meetings. Food security concerns, the ever-changing threat of foodborne illness, rapidly-developing food technologies and marketing innovations challenge all groups to work together. The success of the Conference is a function of its structure, its process and the expertise and collaborative spirit of its members. The objective of the Conference is to promote food safety and consumer protection by:  Establishing a working liaison among governmental agencies, industry, academic institutions, professional associations and consumer groups concerned with food safety;  Coordinating with the USDA and FDA to disseminate information regarding food safety matters that fall under their jurisdiction. Especially with regard to the FDA Model Food Code;  Focusing on and facilitating food protection programs governing the food service, retail food store and food vending segments of the food industry;  Identifying and recommending solutions to problems in the production, processing, packaging, distribution, sale and service of foods;  Advocating sound, uniform procedures that will be accepted by food regulatory agencies and industry and promoting these procedures among regulatory agencies within States, territories and the District of Columbia.